The Center for Enhancing Treatment and Utilization for Depression and Emergent Suicidality (ETUDES) in Pediatric Primary Care

This application for a Practice-based Suicide Prevention Center (PAR-20-286), ETUDES (Enhancing Treatment
and Utilization for Depression and Emergent Suicidality) is a competitive renewal of our current Alacrity P50. We
aim to address the crisis in adolescent suicide, with special attention to Black youth, for whom the rate of suicide
attempts has increased more rapidly than in any other demographic group. We will develop and test effective
methods for identifying and intervening with youth at risk for suicide that can be readily deployed in pediatric
primary care (PPC). We focus on PPC because most youth visit PPC annually, youth are routinely screened
annually for depression and suicidal risk, and mental health treatment delivered in primary care can decrease
disparities in access and outcomes. We focus on the following strategies to reduce suicidal behaviors: (1)
improved identification to complement screening; (2) promote linkages to services and safety planning; and (3)
targeting risk factors for depression and suicidality to prevent the onset of suicidal crises. In the first component
of our signature R01, we will develop prediction models that combine machine learning algorithms using EHR
data and mobile sensing to improve our detection of imminent suicidal risk in a cohort of 2,000 youth, recruited
from PPC. In the 2nd component of the R01, we will conduct a randomized controlled trial on a subset of this
cohort, 900 suicidal youth, comparing usual care to a suite of tools that we have developed to help PPC providers
assess and manage suicidal youth. In previous work, these tools increased physician referrals to mental health
and engagement in treatment, and reduced suicidal behavior. We propose three R34s that target domains that
increase risk for depression and suicidality, namely, online victimization, low activity/anhedonia, and poor sleep.
To address the national crisis of rising suicidal behavior in Black youth, we will recruit a sample that is at least
35% Black, and apply implementation science methods to ensure that all assessments and interventions are
acceptable and effective for Black youth and their families. Moreover, our methods of identification and
interventions target probable sources of racial disparities in suicidal behavior, namely, treatment access, online
victimization, low activity, and poor sleep. This Center renewal convenes a diverse, interdisciplinary team, with
expertise in clinical trials and longitudinal studies, machine learning, mobile sensing, health disparities, and
implementation science. All aims are guided by collaboration with stakeholders, some of whom play leadership
roles in the Center. Primary to the Center’s mission is the training and support of a diverse group of 10 early
career scientists who play critical roles in Center projects. If successful, Center projects should yield predictive
algorithms for imminent suicidal risk to complement annual screening, a care pathway for suicidal adolescents
that can be implemented in PPC and will substantially reduce suicide-related events, and interventions to prevent
depression and suicidal behavior. These tools aim to reduce racial disparities in suicidal behavior by improving
identification, and access, and by targeting risk factors that are more prevalent among Black youth.

Public health relevance
Suicide is the 2nd leading cause of death for adolescents and the rate of suicidal behavior has been increasing rapidly in Black youth. This Center, ETUDES (Enhancing Treatment and Utilization for Depression and Emergent Suicidality) is focused on augmenting the capacity of pediatric primary care to identify, refer, and manage youth at risk for suicidal behavior, with a special emphasis on making sure that the tools we develop to identify, refer, and reduce suicidal risk are effective and acceptable to Black youth and their families. In this Center, we will test novel methods of using health care records and mobile sensing to detect suicidal risk in youth, test interventions to improve referral, treatment engagement, and safety planning in primary care for suicidal youth, and test novel interventions designed to target known risk factors for depression and suicidal behavior, namely poor sleep, low activity, and online victimization that also may contribute to racial disparities in suicide risk.